Administrative Core

Administrative Core Component (2015 Renewal) Project Summary The Administrative Core will oversee the daily running of all resource core components and their staff, and administer the Core research grant. An Advisory Group, consisting of the PI and Co- PI, and the Directors and technicians of each Resource Component, will meet on a 3-monthly basis to discuss any issues related to the Core instruments, technical support and overall usage. Mechanisms to optimize usage and productivity by the core investigators will be addressed regularly. Information on the instruments and services available in from the Resource Components will described in a brochure, which is distributed to each laboratory. Investigators schedule their usage of Core facilities, and all usage is recorded in log books. Administration of the Core grant, with respect to accounting and reporting will be performed by a Grant's Analyst, in coordination with the PI.